AN ADOESCENT WITH CENTRAL HYPOVENTILATION SYNDROME

Serotonergic mechanisms have been implicated in central hypoventilation syndrome. Serotonergic neurons are in an area anatomically close to areas of cardiorespiratory control. We hypothesize that improvement in oxygenation in an adolescent with central hypoventilation was secondary to the addition of fluoxetine. Testosterone administration is believed to have an adverse influence on upper airway patency during sleep. We hypothesize these effects will be obviated by continous delivery of testosterone via a patch. Study is complete. Analysis continues.